Data Science (DS) Core B

SUMMARY/ABSTRACT: Data Science Core B
The objectives of the Data Science (DS) Core are to provide centralized data management, data sharing
tools, and quantitative methods to support all analysis needs for research Projects and Cores. The DS Core
will also provide a mechanism to develop novel methods to facilitate our long-term PAN goals of harnessing
the power of precision medicine to predict individual brain health risks and discover personalized
solutions to better match human lifespan with cognitive healthspan. Core scientists will provide support
for design and analyses for all Projects, including formulation of testable hypotheses, estimation of sample size
and power, multivariate and multivariable classification/prediction analyses and graphical display and
interpretation of results. In addition, the Core will provide expertise in bioinformatic approaches that can be
used in Projects 1, 2 and 4, as well as Cores E and G. The DS Core is a vital component of each research
project in this application through data management as well as the conduit for specific analyses from both
Projects 1 and 2 and the foundation for the overall synthesis of the genomic, cognitive function testing,
biomarkers, and imaging data for all PAN research.